Multi-omic immune profiling

Abstract
We propose single-cell technologies to quantify multiparameter immune markers that provide in-
depth single-cell data for analysis of immune responses to vaccination in our study cohorts. The
shared platforms in this service core provide efficient and reproducible profiling in support of our
research projects with greatly expanded sensitivity and cell-type specificity. To define cell
phenotypes, we will employ mass cytometry or CyTOF (Cytometry by Time-Of-Flight) for
multiparameter single-cell analysis, which uses heavy metal ions as antibody labels and provides
tremendous detail for cellular analysis of immune subsets. To further profile and correlate the
transcriptomes of targeted single cells with immunophenotype, we will employ single-cell cellular
indexing of transcriptomes and epitopes by sequencing (CITE-Seq) for circulating blood cells and
spatial-resolution proteo-transcriptomics via deterministic barcoding (DBiT-seq) in biopsies from
tissues (skin, lymph node). These transcriptomics include in depth sequencing of BCR and TCR
to investigate clonal expansion in the tissue compared to the circulation. To identify molecular
signatures of vaccine responses across our cohorts, we will use a mass spectrometry (MS)-based
MStern blotting-based serum proteomics platform for unbiased discovery of several hundred
proteins with immunological function as an excellent reflection of the immunological state.
Standardization, both at the assay and analytical levels, will allow comparisons and integration of
data across projects. The goals of Core C are to provide a unique and essential resource to
enable the comprehensive characterization of circulating immune cells from blood as well as cells
available from tissue biopsies, with comparative data by CyTOF and RNA-sequencing (RNA-seq),
and matched profiles of proteomic milieu.